ISOLATION AND SEROTYPIC CHARACTERIZATION OF HUMAN AND ANIMAL ROTAVIRUSES

In this project we determined the major antigenic relationships of various rotavirus strains derived from humans and animals. Elucidation of the neutralization specificities of rotavirus is important in order to achieve a more comprehensive understanding of rotavirus epidemiology and for formulation of an effective strategy for vaccination. For example: (i) the bovine rotavirus strain NCDV-Cody which was originally isolated from a diarrheic calf and traditionally considered as the virulent counterpart for the attenuated NCDV-Lincoln (VP7 serotype 6) was shown to carry VP7 serotype 8 and VP4 serotype 6; (ii) the human rotavirus strain 69M (VP7 serotype 8) which was originally isolated from a child with diarrhea in Indonesia, was found to possess a new VP4 neutralization specificity which was closely related antigenically to equine rotavirus H-2 VP4; (iii) the human rotavirus strain MT19 which was originally isolated from a diarrheic child in Brazil was found to have a strong two-way cross-neutralization relationship with porcine rotavirus serotype 5 (OSU strain) and serotype 11 (YM strain); (iv) the vervet monkey rotavirus strain SA11 was shown to possess a distinct VP4 neutralization specificity which was related in a one-way fashion to rhesus monkey rotavirus MMU18006 VP4.